Proteomics of the Proteasome Interacting Network

Abstract Parent Grant: R35GM145249
No changes are proposed to the abstract by the proposed supplement activities.

Public health relevance
Project Narrative Parent Grant: R35GM145249 No changes are proposed to the project narrative by the proposed supplement activities.